ComPASS Collective for Community Engagement (C3E)

The Vanderbilt Institute for Clinical and Translational Research (VICTR) is a highly functional and
integrated clinical and translational (C&T) research infrastructure that has raised the quality and
scientific rigor of the research conducted at Vanderbilt and longstanding partner Meharry, the
nation's oldest historically black academic health science institution. VICTR will contribute to the
mission of the CTSA program while leveraging unique resources and expertise within VICTR's
Hub and elevating the role of health equity in C&T research with these new aims: 1) Leverage
VICTR's strong collaborative energy to enhance team science methodologies, integrate
community engagement principles for all stages of research, and implement programs designed
to support health equity in research; 2) Develop and share multi-dimensional data organization
methods and informatics tools to promulgate innovation, efficiency, quality, and equity in research;
3) Ensure the translational science workforce is diverse and has the skills, knowledge, and
resources necessary to advance translation of discoveries within a health equity framework; 4)
Support the efficiency, quality, representativeness, and impact of local studies and `raise the bar'
for acceptable scientific standards in research conduct; 5) Support the efficiency, quality,
representativeness, and impact of multi-site clinical trials by building and disseminating
streamlining programs and promoting novel trial designs; and 6) Utilize unique institutional
capabilities to enable the conduct of pragmatic trials during healthcare operations and repurpose
existing drugs for new indications.

Public health relevance
The ComPASS Collective for Community Engagement (C3E) aims to catalyze NIH-funded community- driven and community-engaged research by developing and disseminating publicly available resources with tools, and best practices to enable communities to fully participate in health equity research. The overarching goal of C3E is to create a roadmap for sustainable engagement of communities in health equity research. ComPASS Collective for Community Engagement (C3E); Wilkins CH; 7.13.2023